ANALYSIS OF GENES REGULATED DURING NEURONAL INJURY AND REGENERATION

The molecular mechanism by which brief periods of neuronal activity leads to long-lasting changes in the nervous system is thought to involve activation of novel patterns of gene expression, which results in alteration of the physiology of the cell. To understand the mechanisms by which chronic pain and nerve injury alter the nervous system, as well as to identify putative biological regulators involved in these conditions, the molecular mechanisms behind pain and nerve injury need to be better understood. The best characterized genes which are regulated by the pain and nerve injury pathways in the nervous system are the neuropeptide genes. These genes contain unique combinations of cis-acting DNA elements through which signaling has been demonstrated to occur in vitro. Furthermore, individual neuropeptides demonstrates differential responsiveness to the same stimulus making them ideal endogenous "reporter genes" for studying signal transduction of specific stimuli in the nervous system. Using neuropeptide genes that are responsive to nerve injury and pain at the level of the spinal cord and dorsal root ganglia, we will focus on identifying transcription factors which are specific for these signaling pathways in vivo.